K-HEARS: Hearing Health Equity through Accessible Research and Solutions for Korean Americans

PROJECT SUMMARY
Hearing loss is highly prevalent, yet few older adults use hearing aids and disparities in hearing care exist.
Asian Americans have the lowest prevalence of hearing aid use and are one of the fastest-growing segments
of the aging population in the United States. Older Korean Americans (KAs), as predominantly monolingual
first-generation immigrants, represent a population, like other ethnic minority and immigrant populations, who
face barriers to hearing care related to limited English proficiency, poor health literacy, navigational difficulties,
and poverty. The need for affordable, accessible hearing care to meet the needs of more communities is
recognized nationally and community health worker models of care serve a key role in extending access and
delivering culturally responsive care. The HEARS intervention (Hearing Health Equity through Accessible
Research and Solution) is a theory-driven, evidence-based hearing care intervention designed for delivery
through a peer educator model of care that uses over-the-counter hearing technology. HEARS was developed
in-part by the multiple PI team and has since been adapted for delivery to older KAs through faith-based
organizations (K-HEARS). An NIH Stage IB pilot study demonstrated feasibility, acceptability, and preliminary
efficacy of a community health worker (CHW)-delivered hearing care intervention specifically designed for
dyads, an older adult with hearing loss and their communication partner, delivered through ethnic churches. To
build upon these findings, we now propose an NIH Stage III efficacy trial, a 2-arm cluster randomized trial, with
440 dyads of older KAs with hearing loss and their communication partners. Our proposal has the following
aims: Aim 1: To test the effect of K-HEARS on improving communication function and health-related quality of
life among older KAs with hearing loss in comparison to a 6-month delayed treatment group. The trial is
powered to detect a 0.32 effect size or greater score difference on the Hearing Handicap Inventory for the
Elderly-Screening between the immediate and delayed treatment groups at 6 months. Aim 2: To evaluate the
effect of K-HEARS on improving third-party disability (i.e., disability of family or friends due to the health
condition of their significant other) and health-related quality of life among communication partners in
comparison to a 6-month delayed treatment group. Exploratory Aim 1: To test the effect of K-HEARS on the
dyad relationship, as measured by mutuality, 6-months post-intervention. Exploratory Aim 2: To identify the
barriers and facilitators of an ethnic church-based CHW model of hearing care to inform future implementation
and dissemination. This project leverages a multidisciplinary bilingual team of investigators and community
partners with a demonstrated track record. The delivery of hearing care through faith-based organizations has
not been done and no prior research has systematically designed and tested a hearing care intervention
using CHWs with over-the-counter hearing technology in a dyadic sample. The proposed study will inform how
we build local capacity to address the needs of underserved older adults and their loved ones.

Public health relevance
PROJECT NARRATIVE Older Korean Americans, like other ethnic minority and immigrant older adults in the United States, are largely unserved by existing hearing care models. Community health worker-partnered models of hearing care that leverage over-the-counter hearing care and build local capacity, such as through faith-based organizations, are new, critical, and relevant to meeting the hearing care needs of rapidly increasing ethnic minority older adults such as Korean Americans. This first-in-kind, multidisciplinary proposal will build the evidence for a community health worker-partnered model of hearing care specifically designed for older adults and their communication partners with significant language and cultural barriers, strengthening a community-based model of hearing care that will benefit resource-poor ethnic minority older adults and their communication partners more broadly.